The Symmetry-HF Study: Symptom Dynamics and Clinical Biomarkers of Heart Failure in Older Adult Care Dyads After Heart Failure Hospitalization

PROJECT SUMMARY
Heart failure (HF) is a devastating public health issue for America's aging population. It is the primary reason for
hospital admission for older adults, and HF hospitalization for older adult patients carries a much higher burden
of subsequent clinical events (rehospitalization and death) than it holds for younger patients. HF hospitalization
is also associated with concerning outcomes for family caregivers, particularly spouses/partners, who experience
higher degrees of caregiver strain (i.e. burden) and higher mortality risk after their loved one is hospitalized.
Given that worsening symptoms are the primary driver of HF hospitalizations, and timely symptom response is
critical for maintaining clinical stability, a major focus of research has been reducing HF readmissions by targeting
HF patient symptom monitoring and response. However, multiple large HF symptom monitoring trials have been
inconsistently successful in improving patient outcomes post-discharge. Moreover, these studies rarely include
family caregivers, despite the fact that caregivers play a major role in managing symptoms, and they themselves
experience poor health outcomes related to patient hospitalization. The overall scientific goal of this proposal is
to address this critical knowledge gap by examining how patients and their caregiving partners monitor symptoms
together, and testing the overall hypothesis that patients and caregivers who assess symptoms similarly, and
whose assessments accurately reflect changes in clinical stability, will have better symptom response and better
individual and dyadic outcomes. We will enroll 50 older adults hospitalized for HF and their caregiving
spouse/partner for a daily diary study of symptoms and clinical biomarkers of HF progression, and follow them
during the high risk post-discharge period (5 weeks). Leveraging intensive approaches for modeling dyadic
dynamics, we will: (1) Characterize agreement in patient and caregiver assessments of patient HF symptoms
during the post-discharge period; (2) Determine whether agreement in patient and caregiver HF symptom
assessments predicts patient event-risk, caregiver strain, and dyadic symptom response and health status; and
(3) Describe how patient and caregiver symptom assessments change in relation to clinical biomarkers of HF
congestion, and whether triangulating symptom assessments with clinical biomarkers identifies high risk dyadic
patterns of symptom monitoring. This proposed research will be conducted in a resource-rich environment, which
includes an NIH-funded Clinical and Translational Science Center and numerous other institutional and mentor
resources for conducting HF research in older adult couples. The execution of this study, coupled with a
comprehensive training plan (formal coursework, workshops, hands-on and immersion experiences, one-on-one
training), supports the career development goal of this award, which is to provide the Candidate with the skills
necessary (intensive dyadic longitudinal designs and analysis, integration of clinical biomarkers) to transition to
scientific independence and facilitate her long-term goal of developing a sustainable, innovative program of
research to improve the health of patients and caregivers as they manage HF together.

Public health relevance
PROJECT NARRATIVE The health risks related to heart failure (HF) – the fastest growing cardiovascular disorder – are particularly grave for America's expanding population of older adults, for whom HF is the primary reason for hospitalization, and who experience the highest burden of serious adverse outcomes related to HF hospitalization (re-admission and death). HF hospitalization also poses serious health risks for family caregivers, particularly spouses/partners, who are critical to patients' successful post-discharge transition to home, but not without substantial cost to their own health and well-being (increased strain, mortality risk). This proposal employs innovative methods to advance our understanding of how older hospitalized HF patients and spouse/partner caregivers monitor and respond to HF symptoms together during the post-discharge period, and how dyadic symptom monitoring and clinical biomarkers of HF progression can enhance our knowledge of mechanisms of risk, and uncover potential targets for precision interventions to support patient, caregiver, and dyad health.